Research Education Component

ABSTRACT
The overall goal of the San Diego AD-RCMAR is to help diversify the scientific workforce and address
inequities in ADRD-related social and behavioral research. To help achieve that goal, the Research Education
Component (REC) will identify, train and mentor promising early stage investigators (AD-RCMAR Scientists),
including investigators from underrepresented backgrounds and women, to enable them to address ADRD
inequities through independent, rigorous and novel research targeting multilevel factors. The REC will partner
with the Leadership and Administrative Core (LAC), the Analysis Core (AnC), the Community Liaison and
Recruitment Core (CLRC), and our affiliated expert faculty to provide structured training in traditional and
emerging multilevel risk factors of ADRD; innovative behavioral interventions; rigorous study design and
analysis; and best practices for community-engaged research focused on Hispanics/Latinos, limited English
proficient (LEP) and refugee communities. We will provide a multidisciplinary mentored research experience,
infused with principles and practice of diversity, equity, inclusion, and accessibility (DEIA), to enable
researchers to obtain pilot data to help launch their independent careers. The REC will provide leadership
training, longitudinal mentoring, and sponsorship to ensure our Scientists advance in their careers and attain
leadership positions in ADRD-related social or behavioral research.